Molecular Biology/Virus Production

Resource/Service Core: Molecular Biology/Virus Production Module
Abstract:
The Molecular Biology/Virus Production (MB/VP) Module will generate and validate DNA constructs primarily
for use in mammalian cultures/systems in vision research. This module will also purify and concentrate both
lentivirus and adenovirus for subsequent use in immortalized and primary cultures (maintained by individual
investigators and the Cell Culture & Cell Phenotyping Module). The MB/VP Module will provide the following
services: 1) De novo generation of constructs to be used for vision research 2) modification (mutagenesis,
insertion/deletion) of plasmid DNA; 3) maintenance and propagation of DNA glycerol stocks; 4) production and
purification of lentivirus and adenovirus; 5) validation of established DNA constructs and lentivirus/adenovirus
by immunocytochemistry, qPCR and western blotting.
The specific services provided within the MB/VP Module are:
a) site-directed mutagenesis for generating point mutations, insertions, or deletion variants.
b) custom Gibson assembly for development of new DNA fusion constructs driven by desired
promoters of interest.
c) shRNA and CRISPR/SpCas9 plasmid generation for knockdown/out experiments.
d) full sequencing of generated constructs, extensive documentation, and maintenance of DNA stocks
for future use.
e) small to large scale endotoxin free plasmid purification for downstream applications.
f) thorough confirmation of produced constructs at the transcript, protein and subcellular level.
g) generation of high-purity lentivirus and adenovirus for use in vitro or in vivo.
Overall, the MB/VP Module will support a range of enabling recombinant DNA technologies and provide the
assistance and expertise required to test unique hypotheses posited by vision scientists at UTSW and
neighboring institutions.